GLUCONEOGENESIS IN THE VERY LOW BIRTH WEIGHT INFANT

The purpose of this study is to compare the contribution of gluconeogenesis to hepatic glucose production of preterm infants given glucose alone vs. a combination of either glucose and amino acids, glucose and lipid or glucose, amino acids and lipid during the first 48 hours of life. The hypotheses to be tested are: 1) amino acids, lipid and a combination of both enhance gluconeogenesis in the VLBW infant and 2) substitution of IV amino acids, lipid or both for glucose diminish hyperglycemia without increasing the risk of hypoglycemia.